Gathering, Learning & Initiating: Setting the Stage for Community-engagement in Women's Health in SW Alaska

Summary: As in the US, Alaska’s increased maternal mortality (63% between 2014-2018) has been
associated with substance use disorders (SUD) at disproportionately higher levels in rural southwest Alaska
communities. To address the underlying connections between women with SUD and maternal health services,
research and preventative care intervention designs must be tailored to the local community. Development of
locally appropriate research and intervention strategies requires engaging the local communities and health
care agencies as local stakeholders—particularly with sensitive and unexplored issues of intersectional
populations. Aim 1 of this project proposes to lay the groundwork for a maternal health study in southwest
Alaska by engaging interested local women and health agencies to prepare for future research in these
communities through the creation of a Women’s and Maternal Health Community Advisory Board (WMH CAB),
using an adapted NIH-based CAB toolkit (Kubicek & Robles, 2016) as a guide. This toolkit, part of a Resource
for Integrating Community Voices into Research Study package, compiled by the NIH-based Southern
California Clinical & Translational Science Institute, provides an overview of how to develop and maintain a
community advisory board (CAB) for research studies to integrate community perspectives. While there is
emphasis on the importance of considering ways to make the CAB a supportive environment to ensure equal
participation— the strategies listed for ‘identifying members, integrating them into the research process,
maintaining engagement over time, and meeting facilitation’ did not necessarily take into account the
remoteness or difficulty of travel in rural Alaska, the importance of observing subsistence or commercial fishing
seasons, or the layers of different tribal and regional agencies to be navigated. The use of these strategies,
then, are appropriately adjusted to improve the chances of community interest and involvement; and five
smaller local-based CABs proposed, instead of one larger one. Project uses already-existing ties with the
regional AHEC (Area Health Education Centers) offices in the area for making the introductions and
recommendations of WMH CAB members for each respective communities; and focus group or talking circle
meetings will take place to engage in addressing how best to approach research on the Women’s and
Maternal health issues in their community. Aim 2 of this project is focused on the development and executions
of workshops to train a pool of local undergraduates for placement as local interviewers when the resulting
designed research begins with subsequent grant funding. Local-based AHEC graduate student(s) are included
in this phase to help facilitate the community meetings; research and intervention design; and to conduct
workshop activities for the local attendees to become interviewers for the future studies. CABs from five (5)
southwest Alaska communities, in the service areas of AHEC regional offices, will be tasked with providing
input on research and intervention designs and workshop components.

Public health relevance
Narrative: This “Setting the Stage” project is designed to assist with forming five (5) southwest Alaska community-based advisory boards to facilitate engagement in Women’s and Maternal Health opportunities and concerns in the local area. This engagement is shown to be an integral preliminary step to building trust for community participation in future research and initiatives directed at improved outcomes in women’s and maternal health. This activity enables a partnership with local input on research design and participation on issues surrounding maternal health in local communities and engages local AHEC graduate students in community-based participatory research project development.